Scholars in BioMedical Sciences (SBMS) Training Program

Abstract
We are requesting support for the Scholars in BioMedical Sciences (SBMS) Program. This training
program is crucial to introduce graduate students to the concepts of medical research and to spawn a
new generation of translational science-minded and trained scientists. The SBMS provides a mentored
research training program for Ph.D. candidates at their second and third years. In the last ten years,
the program has trained 41 students with support from the NIH (T32), the School of Medicine, the
Graduate School and the Office of the Provost, while 21 students are still in training. Students are
exposed to the vast array of medical research opportunities available to physicians at our large medical
school campus. They take coursework in human pathobiology, clinical trials, data analysis and clinical
research ethics, and engage in basic, translational, or clinical research projects under the supervision
of a clinical faculty mentor representing any of the clinical disciplines. The students are financially
supported by the program for one year. The goals of the SBMS are to: (1) Expose basic science
students to high quality and intensive clinical medicine research opportunities; (2) Provide graduate
basic science students with an understanding of the method and critical analysis of clinical, patient-
oriented research; (3) Promote research experiences that can develop into longer-term student-faculty
mentoring relationships; (4) Provide trainees with experience in scientific presentation in the Annual
SBMS Symposium, and other scientific meetings at a regional or national level; (5) Provide students
with a high quality didactic program in ethical, responsible, rigorous and well controlled human patient
research, (6) Prepare the basic science graduate students to act as liaisons between basic and clinical
science and (7) Prepare the students for a career at work at the interface of basic biomedical science
and clinical research. This T32 application requests support for 6 students/year to be appointed for one
year. It features a diverse group of faculty who are experienced in the pursuit of basic, translational and
clinical biomedical research and committed to enhancing the experience of our outstanding basic
science students and mentoring a new cohort of translational medicine-trained investigators.

Public health relevance
Narrative The SBMS training program provides didactic training in translational science and supports clinical research opportunities for PhD candidates starting their second or third year of doctoral training. The goal of this program is to expose the students to biomedical research, promote an understanding of the challenges of medical research, bridge the gap between basic biology and medical practice and provide relevance and urgency to basic science research and establish collaborations between basic and clinical researchers.